National Xenopus Resource Center

Project Summary – Overall Component
This project supports continued funding for the National Xenopus Resource (NXR) located at the Marine
Biological Laboratory in Woods Hole, MA. The NXR is one of the top priorities for the Xenopus community. The
NXR was established in 2010 to serve as a national resource for researchers working with the Xenopus
amphibian model system, which includes two species Xenopus laevis and Xenopus tropicalis. The NXR serves
as a national repository for community-generated animal stocks as well as serving as an advanced training
venue that greatly facilitates productivity for a multitude of researchers. It is a community-oriented resource
center that serves all Xenopus researchers, including individuals from large research-focused universities to
small liberal arts colleges. As biological research becomes ever more complex, often requiring specialized animal
lines and involving diverse technologies, individual laboratory units become insufficient to meet all of the
demands required for addressing significant biological problems and a centralized repository or stock center
becomes essential. There are four aims to this grant. First, the NXR will maintain current stocks of frogs as well
as obtain new lines making them available to the community; this includes special inbred, wild type and mutant
lines of both species. In the second aim we outline the NXR research services that meet community demand,
including creation of transgenic and mutant animals. In the third aim we outline the resources that we have
developed to enable novel Xenopus research, including advanced training workshops (bioinformatics, advanced
imaging, genome editing) taught by experts in each field that serve to teach and propagate specialized
techniques. The last aim is the applied research aim. In Aim 4 we outline our goals to define the integration sites
for our transgenic animals.

Public health relevance
Project Narrative Research using the amphibian Xenopus, because of unique advantages as an experimental system, has revealed key insights in many domains of biomedical research, including cell biology, development, neurobiology, physiology and signal transduction, achievements that are supported by having a centralized National Xenopus Resource for raising and distributing animals and disseminating the most current technology to the research community. In each of these areas research has led to significant insights about the causes of human diseases, including cancer, birth defects, diabetes and neurological disease, and provided key underpinnings for the field of regenerative medicine.